Tumor evolution in response to treatment

Tumor evolution is a dynamic process with continuous changes of tumor cells and the interactions with the tumor microenvironment. Based on single-cell transcriptomic profiles from liver cancer patients before and after treatment, we developed a novel machine learning-based consensus clustering approach to track cellular states of malignant and non-malignant cells. We demonstrated that a tumor's evolutionary trajectory may change over time in response to immunotherapy. We suggest osteopontin may be a candidate regulator of tumor evolution in response to treatment.